Uncovering Nodal signaling and transcription factor interactions in somitic mesoderm development using single-cell deep learning methods

PROJECT SUMMARY/ABSTRACT
Major gaps remain in our knowledge of how transcription factors (TFs) interact to bind target
cis-regulatory elements (CREs) and dictate gene expression during development. There are ~1600 TFs in
vertebrates, and therefore traditional approaches of genetic screens with TF pairwise knockouts would require
>2.5 million experiments. Even with high throughput methods, this is not experimentally feasible. I will build
novel computational tools and deep neural networks and use multiplexed high-throughput single-cell Assay for
Transposase-Accessible Chromatin (scATAC-seq) data from zebrafish throughout development. These deep
neural networks will be used for in silico experiments to model CRE interactions to learn the cell-type
specific regulatory syntax of T-box proteins during development. These combinations of TF-TF
interactions from in silico experiments will then be tested with targeted CRISPR-Cas9 mutagenesis followed by
phenotype profiling with in situ hybridization and high-throughput low-cost scATAC and scRNA-seq.
In Aim 1, I will make a genome-wide cis-regulatory map of cell-type specific gene regulation of
zebrafish to uncover the role of Nodal signaling in zebrafish somitic mesoderm development. In zebrafish,
mutations to Nodal, a ligand to TGF-Beta receptor proteins, cause a phenotype of aberrantly undifferentiated
trunk somitic mesoderm and correctly differentiated tail somitic mesoderm. The mechanisms driving the
differences between these somites are unknown. To resolve this mystery, I will generate single-cell time series
wild-type and Nodal deficient embryos across the continuum of zebrafish development using multiplexed
high-throughput scATACseq and scRNAseq data. Computationally linking these data will represent a
comprehensive reference of zebrafish CRE and transcriptional development and a valuable resource for all
zebrafish biologists. By improving the software package, Cicero, to include flexible Poisson lognormal network
models, we can achieve the resolution necessary to find novel cell-type specific differences in
enhancer-promoter links during development and perturbationc
In Aims 2, I will train and validate a deep learning neural network model to predict pairs of transcription
factors that interact to activate cell-type specific gene programs. I will use these data and computational
tools to perform in silico experiments to learn the cell-type specific regulatory syntax of T-box TFs
during development. After performing in silico experiments using this neural network, I will rank candidate
TF-TF interactions to test using high-throughput methods for targeted CRISPR-Cas9 mutagenesis to knock out
TFs. I will apply this method to uncover the cis-regulatory syntax that allows T-box family transcription factors
to exert their DNA loci specificity.

Public health relevance
PROJECT NARRATIVE The proposed research will create a cis-regulatory map of how Nodal signaling and T-Box transcription factors, affect cell-type specification during somitic mesoderm development. Improvements to high-throughput single-cell technologies and computational methods will be developed to uncover TF interactions during the differentiation of somitic mesoderm in zebrafish. The success of deep learning methods for in silico experiments to predict TF-TF interactions paired with high throughput CRISPR mutagenesis of F0 zebrafish would represent a significant advance toward understanding gene regulation required for development.